Development of a Targetable Transposase Platform for Precision Gene Integration in Human Cells

PROJECT SUMMARY
Current genome editing technologies, such as CRISPR nucleases, are effective for gene knock-outs but face
limitations in the precise and efficient insertion of large DNA fragments into specific genomic sites, particularly
in non-dividing cells. These limitations arise from the reliance on double-strand breaks and error-prone host
repair mechanisms, which often lead to unintended mutations and off-target effects. Additionally, the inefficiency
of homology-directed repair further constrains the potential of these methods for gene therapies requiring stable
and accurate gene insertion. Consequently, a more efficient, safe, and precise system is needed. This project
seeks to address these challenges by developing a platform technology based on the piggyBac (pB)
transposase, which facilitates precise DNA insertion with minimal off-target effects. The approach incorporates
rational design and directed evolution to optimize the transposase, enabling the delivery of large transgenes to
specific genomic sequences. Unlike traditional gene editing methods, this technology actively integrates large
DNA fragments without relying on double-strand breaks or homology-directed repair, making it a versatile tool
for both therapeutic and research applications. Preliminary data indicate that the pB transposase, when modified
with custom DNA-binding domains, achieves targeted DNA integration. Key mutations in the transposase’s
native DNA-binding domain have significantly reduced off-target insertions while preserving its ability to efficiently
deliver transgenes to specific genomic sites. This proposal aims to further refine the system through phage-
assisted continuous evolution (PACE) to enhance both the efficiency and specificity of the transposase,
establishing a highly effective gene therapy platform. The project will optimize the pB transposase for site-specific
integration by tethering it to custom DNA-binding proteins. Structural modeling will guide these modifications,
reducing off-target effects and enhancing targeted insertion into the human genome. PACE will be applied to
evolve pB transposase variants with improved efficiency and specificity, rapidly scanning large sequence spaces
to identify variants that are suitable for therapeutic applications. The clinical potential of this technology will be
demonstrated by using the evolved pB transposase to deliver a chimeric antigen receptor (CAR) gene to human
T-cells, highlighting its ability to efficiently and precisely deliver therapeutic genes. This platform technology
represents a significant advancement over existing genome editing methods by enabling the precise, efficient,
and safe integration of large DNA fragments into non-dividing cells. It offers broad applications in the treatment
of genetic diseases and biomedical research, where the ability to integrate large or multiple genes at specific
genomic locations is essential. By addressing the limitations of current methods, this approach has the potential
to revolutionize gene therapy, providing a robust and versatile tool for a wide range of genetic interventions.

Public health relevance
PROJECT NARRATIVE This project aims to develop a highly specific and efficient gene therapy platform using the piggyBac transposase to enable precise insertion of large DNA fragments at specific genomic sites. By optimizing the piggyBac transposase through rational design and directed evolution, this research will address the limitations of current gene-editing technologies. The outcomes of this project will provide safer and more effective therapies for genetic diseases by minimizing off-target effects and enhancing the precision of gene delivery.